Administrative Core

PROJECT SUMMARY
The Administrative Core will provide the scientific leadership and operational structure necessary for the
planning, implementation, management, and supervision of all activities of the University of Wisconsin Prostate
Cancer SPORE. Embedded within the University of Wisconsin Carbone Cancer Center (UWCCC) Office for
Translational Research Services (OTRS), the Administrative Core will centrally provide a wide variety of
administrative coordination, oversight, and research support services to all leaders, co-leaders, investigators and
core directors. It will offer these services in a centralized manner, to promote efficiency and ensure that all
SPORE research and activities are focused, connected, that complex scientific objectives are met, and existing
cancer center resources are utilized and not duplicated. The Administrative Core will also provide the oversight,
monitoring and auditing required to ensure projects are meeting translational endpoints and reach human
application within five years, consistent with the SPORE mission.
Specific Aims of the Administrative Core are: 1) Leadership (scientific leadership); 2) Administrative
management; 3) Planning and evaluation activities; 4) Institutional support (management of unencumbered
institutional resources provided); 5) Integration of SPORE within UWCCC, UW-Madison, and regional
partnership alliances; 6) Prostate cancer patient population (efforts to increase diversity in clinical and
translational research populations); 7) Data management; and 8) Communications.

Public health relevance
PROJECT NARRATIVE The ultimate goal of the Administrative Core is to provide the operational structure necessary to support the UW Prostate Cancer SPORE Executive Leadership, Project Leaders and Development and Core Directors for the successful conduct of this grant. This grant is directly relevant to the mission of the National Cancer Institute as it is aimed at developing new treatments, and improving existing treatments, for prostate cancer.